Yale SPORE in Skin Cancer

OVERALL: PROJECT SUMMARY
The Yale SPORE in Skin Cancer (YSPORE), now in its second funding cycle, involves a broad range of projects
and investigators with diverse expertise, whose goal is to decrease mortality from melanoma by developing
methods to prevent the disease and treat patients once it metastasizes. YSPORE leans on the immense scientific
and clinical strengths at Yale School of Medicine and Yale Cancer Center including immunobiology, genetics,
epigenetics, quantitative sciences, immuno-oncology, nanoparticles, animal models, and digital pathology.
YSPORE investigators have made major contributions in recent years to understanding the effects of ultraviolet
damage on melanocytes, determining the molecular events that lead to melanoma progression and developing
novel immune therapy approaches for melanoma patients with advanced disease. Recent advances in systemic
therapies for advanced melanoma, particularly immune checkpoint inhibitors, that prolong survival, pose a new
set of challenges for clinicians which will be addressed by the proposed research program. The YSPORE
translational research team proposes to accomplish the objective of decreasing morbidity and mortality from skin
cancer through five specific aims: Specific Aim 1: Develop novel bioadhesive sunscreens and triplet-state
quenchers for prevention of melanoma and test them in pilot clinical trials; Specific Aim 2: Develop liquid biopsy
approaches for melanomas that metastasize to sites that are difficult to biopsy. Liquid biopsies will then be
studied in patients treated with PD-1 inhibitors to identify predictors of response and determine mechanisms of
resistance; Specific Aim 3: Study novel drugs that target the epigenetic modifier KDM5, to enhance T cell
infiltration in tumors that are unresponsive to immune checkpoint inhibitors; Specific Aim 4: Develop new
approaches to overcoming resistance to PD-1 inhibitors by co-targeting the innate and adaptive immune
systems; and Specific Aim 5: Develop new research directions to decrease mortality from melanoma and
nurture the next generation of translational investigators focusing on skin cancer through a Developmental
Research Program and a Career Enhancement Program. We propose three cores (Administrative Core,
Biospecimen Core and Biostatistics and Bioinformatics Core) to support the projects, their clinical aims,
mechanistic studies, and biomarker development for clinical application. The Projects and Cores are designed
to be highly coordinated with the goal of maximizing resources and potential impact. New collaborations will be
established during the funding period through the Developmental Research Program with the support of the
Administrative Core. Collaborations with other institutions and skin cancer SPORE sites will be fostered by the
Administrative Core. These coordinated efforts will enhance analysis of patient samples, use of cell cultures and
animal models, and development of predictive biomarker assays. Our purpose is to translate the innovative
approaches proposed here to clinical therapies for prevention and treatment of skin cancer.

Public health relevance
OVERALL: PROJECT NARRATIVE The goal of the Yale SPORE in Skin Cancer is to decrease morbidity and mortality from melanoma. We have assembled a group of interdisciplinary investigators to conduct a series of bench-to-bedside studies aimed at preventing melanoma and improving outcomes for patients in whom melanoma has metastasized. These studies will capitalize on advances made in the last funding period and build on the extensive resources, such as tumor samples, animal models, and novel drugs and technologies, developed in the past decade by YSPORE investigators.